MECHANISM OF DELAYED HYPERSENSITIVITY AND TUMOR GRAFT REJECTION

The goals of this project are to analyze the genetic mechanisms by which immunogenic tumors escape host immune responses and the genetic basis of transplantation antigens of chemically- induced tumors.